Randomized Controlled Trial of a Relaxation Intervention to Improve Newborn Growth and Maternal Well-being

PROJECT ABSTRACT
In low- and middle-income countries (LMIC), growth impairment is common during infancy and has a
devastating impact on health, increasing the risk of infectious disease, cognitive impairment, and overall
morbidity and mortality. Low birth weight (LBW) infants are at especially high risk of these adverse outcomes
and often struggle to grow. Under such conditions, maternal postpartum stress and anxiety levels are often
greatly elevated, interfering with maternal well-being and further contributing to poor infant health. Recently,
randomized controlled trials conducted in high-income countries reported that audiorecordings promoting
relaxation during breastfeeding increase milk transfer from mother to infant and improve infant growth while
reducing maternal stress and anxiety. However, no studies have yet tested this intervention in a low-income
country, where the factors contributing to infant growth impairment and maternal stress may differ from those in
high-income settings. To evaluate whether an audiorecording promoting relaxation during breastfeeding can
improve infant growth and bolster maternal well-being in a low-income country, we propose the Relaxation
Intervention to Improve Newborn Growth and Maternal Well-being (RING-MW) study. RING-MW will begin by
using qualitative and quantitative methods to develop and adapt an audiorecording promoting relaxation during
breastfeeding so that it is culturally relevant and feasible for use by the local postpartum population. RING-MW
will then assess the efficacy of this adapted audiorecording in a pilot randomized controlled trial which will
enroll 100 recently postpartum mothers experiencing moderate-to-high stress and their breastfeeding, LBW
newborns in Kampala, Uganda. Enrolled mother-infant dyads will be randomly assigned either to an
audiorecording promoting relaxation during breastfeeding (intervention group) or to usual care (control group).
Baseline data will be collected at enrollment, and mothers and infants will be followed at 1, 2, 4, and 12 weeks
after birth and assessed for infant growth, feeding, and adverse events; milk intake and immunoglobulin levels;
and maternal stress, anxiety and depression. The effect of treatment assignment on these outcomes will be
reported using both intention-to-treat and per protocol approaches, and metrics will be collected to inform
future implementation work should the intervention demonstrate efficacy. The feasibility of the proposal is
supported by the investigators’ previous successful collaborations at the enrolling hospital in Kampala,
Uganda. Audiorecordings promoting relaxation during breastfeeding are an inexpensive intervention and are
potentially highly scalable in LMIC. If our intervention demonstrates efficacy in the low-income country setting
of Uganda, we hope it may be possible to conduct a future larger clinical trial to examine effectiveness,
informed by the implementation metrics gathered in this pilot work. Given the scalability of audiorecordings, if
an audiorecording promoting relaxation during breastfeeding were to be shown effective at improving infant
growth or maternal well-being, the potential for global health benefit could be substantial.

Public health relevance
PROJECT NARRATIVE Infant growth impairment is common in low-income countries and greatly increases the risk of adverse infant outcomes including infectious disease and cognitive impairment. Recently, randomized controlled trials in high- income countries have demonstrated that an audiorecording promoting relaxation during breastfeeding can improve growth for at-risk breastfeeding infants, perhaps by reducing maternal stress and improving maternal well-being. In this application, we propose to study whether such an intervention might be efficacious in a low- income country by conducting the randomized controlled trial, “Relaxation Intervention to Improve Newborn Growth and Maternal Well-being (RING-MW),” which will enroll 100 mothers and their LBW newborns hospitalized in a high-stress setting in Uganda, randomly assign them either to an audiorecording promoting relaxation during breastfeeding (intervention) or to usual care (control), and follow them at 1, 2, 4, and 12 weeks after birth to assess infant growth, adverse events, milk intake, feeding behavior, and maternal well- being.